Effects of vaping-induced oxidation on nicotine analogs e-cigarettes

ABSTRACT
The vaping landscape has significantly evolved since they were introduced, continuously gaining popularity
among adolescents and young adults. Originally marketed as a smoking alternative or cessation aid, vaping
devices now attract youth with various flavorings and addictive substances, including different forms of nicotine.
Despite regulatory efforts, youth vaping remains a significant issue, especially with the rise of disposable devices
like cool mint- and fruit-flavored vapes. Concerns about the safety of these devices compared to traditional
cigarettes persist, as harmful compounds have been identified in vape emissions. The emergence of alternative
nicotine formulations, such as 6-methyl nicotine, further complicates the situation. Research indicates that 6-
methyl nicotine has similar physiological effects to nicotine but raises more significant safety concerns,
necessitating further research and regulatory attention. Specifically, initial studies indicate that 6-methyl nicotine
exhibits higher toxicity and greater activation of nicotinic receptors than nicotine, presenting a public health
challenge due to gaps in understanding its long-term effects and potentially higher addictive attributes. To
address these risks, this project hypothesizes that vaping-induced aerosolization of 6-methyl nicotine vaping
products modifies the chemical composition of these e-liquids and generates toxic aerosol mixtures. The project
aims to evaluate the chemical composition of 6-methyl nicotine and nicotinamide vapes before and after
aerosolization and investigate their toxicity in human bronchial epithelial cells (hBECs), an initial target for inhaled
e-cigarette aerosols. By integrating chemical characterization with in vitro exposures in our newly developed
Vaping Product Exposure System (VaPES), these goals will be accomplished through two specific aims. Specific
Aim 1 will analyze the chemical composition and metabolism of 6-methyl nicotine and nicotinamide vaping
devices before and after vaping using targeted and nontargeted mass spectrometry. This will identify active
ingredients, contaminants, and novel oxidation products formed during aerosolization. Specific Aim 2 will assess
the toxicity of 6-methyl nicotine and nicotinamide compared to nicotine e-cigarettes in hBECs. This will involve
evaluating cytotoxicity and gene expression, untargeted metabolomic and proteomic profiles in hBECs, and
determination of chemical biomarkers of exposure. Computational modeling tools will be used to integrate
chemical/transcriptomic/metabolic signatures associated with dysregulated cellular pathways in hBECs. The
project's overarching goals are to provide comprehensive chemical characterization and comparative toxicity
analysis of nicotine analog vaping products, inform regulatory decision-making, and lay the foundation for further
toxicity testing. Utilizing advanced chemical and biological methods, this research aims to identify biomarkers of
exposure and elucidate the potential health impacts of inhaling these new vaping products.

Public health relevance
NARRATIVE The vaping landscape has significantly evolved, with rising popularity among adolescents and young adults, driven by various flavorings and addictive substances, including different forms of nicotine. Despite regulatory efforts, youth vaping persists, particularly with the increase in disposable devices and the emergence of alternative nicotine formulations like 6-methyl nicotine, which presents higher toxicity and safety concerns. This project aims to evaluate the chemical composition and toxicity of 6-methyl nicotine and nicotinamide vapes, utilizing advanced mass spectrometry and in vitro exposure systems to inform regulatory decision-making and further research on the health impacts of these vaping products.